RR&D Senior Research Career Scientist Award

Robert L. Mauck, PhD is a Research Career Scientist and Co-Director of the Translational
Musculoskeletal Research Center at the Corporal Michael J. Crescenz VA Medical Center in Philadelphia.
He is also the inaugural Director of the new RR&D-funded Cartilage Regeneration using Advanced
Technologies to Enable (CReATE) Motion Center. At the University of Pennsylvania, he is the Mary Black
Ralston Professor of Education and Research in Orthopaedic Surgery and Professor of Bioengineering at the
University of Pennsylvania. He is also the Director of the McKay Orthopaedic Research Laboratory. At Penn,
Dr. Mauck also served as the Co-Director of the Program in Musculoskeletal Regeneration in the Institute for
Regenerative Medicine (IRM), is the Associate Director of the Penn Achilles Tendinopathy Center for
Orthopaedic Research Translation (PAT-CORT), co-directs the Penn T32 Training Program in Orthopaedic
Bioengineering, and is a founding member of the Center for Engineering Mechanobiology (CEMB).
Dr. Mauck’s research program is focused on the engineering and mechanobiology of musculoskeletal tissues,
with a particular interest in restoring articular cartilage, the knee meniscus, and the intervertebral disc. Dr.
Mauck’s team uses mechanical and molecular analyses to explore native tissue structure function relationships
and employs this information to enhance the functional properties of engineered constructs through focused
technology development. His work explores progenitor cell function and efficacy in a variety of biomaterial
contexts and across multiple length scales, from subcellular biophysical properties to translation of engineered
constructs in large animal models and humans. The goal of his research program is to develop and deploy novel
regenerative therapies to improve musculoskeletal health in Veterans and the population as a whole.
Dr. Mauck is supported by the Department of Veterans Affairs, the National Institutes of Health, the National
Science Foundation, and several foundations and private organizations. He is an active member of the American
Society for Mechanical Engineers (ASME), the Orthopaedic Research Society (ORS), the Tissue Engineering
and Regenerative Medicine International Society (TERMIS), the Biomedical Engineering Society (BMES), and
the International Cartilage Repair Society (ICRS). Dr. Mauck is the co-Editor-in-Chief of the Journal of
Orthopaedic Research Spine and serves on the editorial board of the Journal of Orthopaedic Research, the
Journal of the Mechanical Behavior of Biomedical Materials, and the Journal of Experimental Orthopaedics. He
has published >270 manuscripts (cited >17700 times, ISI h-index: 70), >300 abstracts, and >12 book chapters.
Dr. Mauck has been recognized for his contributions to the field with the ISSLS Prize in Biomechanics (2008),
the YC Fung Young Investigator Award from the ASME (2009), the BMES-CMBE ‘Rising Star’ Award (2011),
the Penn Medicine Montague Research Prize (2013), the Kappa Delta Young Investigator Award from the
American Academy of Orthopaedic Surgeons (2015), the Berton Rahn Research Award from the AO Foundation
(2017), the Van Mow Medal from the ASME (2022), and the Grood Interdisciplinary Team Science Medal from
the ASME (2023). He was inducted to the College of Fellows of the American Institute for Medical and Biological
Engineering (2014), as a Fellow of International Orthopaedic Research (FIOR) of the International Combined
Orthopaedic Research Societies (ICORS) College of Fellows (2019), and a Fellow of the Orthopaedic Research
Society (2021). He was also selected as the ‘Research Scientist of the Year’ at the CMC VAMC (2019) and
became a VA RR&D Research Career Scientist in that same year.

Public health relevance
This Senior Research Career Scientist (SRCS) application by Robert Mauck of the Corporal Michael J. Crescenz VA Medical Center in Philadelphia seeks support for a research program focused on issues of high relevance to the Veteran population. Dr. Mauck develops novel regenerative tools to improve outcomes and restore function in Veterans whose mobility has been compromised by musculoskeletal (MSK) injury or degeneration. Dr. Mauck develops novel material and stem cell-based therapeutics that are intended to speed the repair or replace cartilage, meniscus, and disc, and his team is actively translating these technologies into pre-clinical large animal models and humans. In addition to his scientific pursuits, Dr. Mauck is committed to building VA-focused collaborative research efforts and supporting the next generation of VA-based scientists and has mentored multiple clinicians/scientists to Career Development Awards through the RR&D Service.